Molecular physiology of Phox2b-expressing RTN chemoreceptor neurons

PROJECT SUMMARY
A discrete group of intrinsically CO2/H+-sensitive brainstem neurons located in the retrotrapezoid nucleus (RTN)
provide a critical state-dependent and CO2-modulated excitatory drive to respiratory and arousal circuits. RTN
dysfunction is implicated in various syndromes associated with reduced arousal and ventilatory responses to
high CO2 (e.g., sudden infant death, SIDS; congenital central hypoventilation, CCHS). RTN neurons express the
transcription factor Phox2b throughout life. Phox2b expression is required for embryonic specification of RTN
neurons, and RTN dysgenesis is the prominent neuropathological feature in mouse genetic models that incorpo-
rate CCHS-relevant Phox2b mutations and phenocopy its cardinal signs (i.e., hypoventilation, blunted arousal
and ventilatory responses to CO2). The broad transcriptional role of Phox2b has not been determined in RTN
neurons, and it remains unclear whether continued postnatal expression of Phox2b is required to maintain the
specific molecular, cellular, and network features of RTN neurons. This proposal examines gene regulatory func-
tions of wild type and CCHS-relevant polyalanine expansion mutants of Phox2b in RTN neurons, and the rele-
vance of Phox2b-regulated genes for RTN function (Aim 1) and connectivity (Aim 2). In Aim 1, we test the
hypothesis that persistent expression of wild type Phox2b regulates genes critical for RTN neuron effects on
breathing and arousal. Specifically, we use viral approaches to deplete or mutate Phox2b in RTN neurons and
determine effects on: [1.1] CO2-regulated breathing and arousal, by combined EEG and whole animal plethys-
mography; [1.2] the full RTN transcriptome, by single cell RNA sequencing; and [1.3] direct transcriptional
regulation of GPR4 and TASK-2, two molecular CO2 detectors in RTN neurons. Exciting preliminary data reveals
that Phox2b knockdown in RTN neurons results in basal hypoventilation, respiratory dysrhythmia, and blunted
CO2-stimulated breathing and arousal. Moreover, our initial candidate gene analysis suggests that GPR4 and
TASK-2 may be regulated in cis by Phox2b. In Aim 2, we test the hypothesis that RTN neurons target multiple,
phenotypically distinct brainstem neuronal groups that are sustained by Phox2b expression. Specifically, we
use anterograde and trans-synaptic genetic markers with single cell RNA sequencing to: [2.1] characterize the
molecular phenotype of direct postsynaptic targets of RTN neurons in brainstem regions linked to CO2-regulated
breathing and arousal; and [2.2] examine whether those specific cellular targets are disrupted in CCHS mouse
models or after RTN-specific Phox2b depletion/mutation. Initial transcriptomic analysis of single RTN postsyn-
aptic cells identified genetic markers suggestive of known neuronal subclusters, and exciting preliminary data
indicates that Phox2b expression in RTN neurons is required to maintain appropriate network connectivity to
these physiologically important brainstem target regions.
Collectively, the proposed studies will provide novel information regarding the role of Phox2b in maintaining
the molecular, cellular, and network properties for the critical respiratory and arousal functions of RTN neurons.

Public health relevance
PROJECT NARRATIVE A population of Phox2b-expressing excitatory neurons in the retrotrapezoid nucleus (RTN) of the ventral medulla oblongata provide a CO2/H+-chemosensory and integrative role in regulating breathing and arousal. Phox2b is a transcription factor that is required for proper development of several brainstem autonomic nuclei and mutated in congenital central hypoventilation syndrome (CCHS), with RTN dysgenesis implicated in the associated alveolar hypoventilation and loss of CO2-dependent arousal and ventilatory reflexes. The transcriptional role of Phox2b has not been defined in any relevant neuronal cell group, and it remains to be determined how its persistent expression contributes to maintenenace of molecular, cellular and network characteristics of RTN neurons. Here, using novel mouse lines and viral constructs for cell-selective gene manipulation in RTN neurons, we examine gene regulatory functions of wild type Phox2b and CCHS-relevant polyalanine mutants to characterize the Phox2b-regulated transcriptome in RTN neurons and determine the role of Phox2b in maintaining RTN neuronal networks and function relevant to control of breathing and arousal.